Building a classroom game economy to improve mathematical reasoning and prepare K-5 students for success in STEM learning

Project? ?Summary/Abstract There? ?is? ?an? ?enormous? ?need? ?for? ?qualified? ?people? ?to? ?pursue? ?careers? ?in? ?STEM? ?(Noonan, 2017).? ?However,? ?the? ?lack? ?of? ?a? ?strong? ?foundation? ?in? ?mathematics? ?means? ?students? ?are? ?less? ?likely to? ?pursue? ?STEM? ?majors? ?and? ?careers? ?(Chen,? ?2013;? ?Griffith,? ?2010;? ?Huang,? ?Taddese,? ?&? ?Walter,? ?E, 2000;? ?Kokkelenberg? ?&? ?Sinha,? ?2010;? ?Lowell? ?et.? ?al.,? ?2009).? ?Students? ?from? ?low-income? ?families, women,? ?and? ?underrepresented? ?minorities? ?are? ?also? ?less? ?likely? ?to? ?major? ?in? ?STEM? ?(Bettinger,? ?2010; Griffith,? ?2010;? ?Hill,? ?Corbett? ?&? ?Rose,? ?2010;? ?Kokkelenberg? ?&? ?Sinha,? ?2010).? ?Improving? ?math learning? ?in? ?the? ?elementary? ?grades? ?is? ?important? ?to? ?ensure? ?children? ?have? ?the? ?essential foundational? ?skills? ?and? ?strong? ?self-efficacy? ?beliefs? ?to? ?be? ?able? ?to? ?succeed? ?with? ?later? ?mathematics and? ?pursue? ?careers? ?in? ?STEM.? ?With? ?this? ?Fast-Track? ?grant,? ??Class? ?Store? ??(?CS?)?,? ?we? ?propose? ?to transform? ?the? ?way? ?in? ?which? ?students? ?learn? ??Number? ?and? ?Operations? ?in? ?Base? ?Ten.?? ??CS? ??will? ?be? ??an engaging,? ?commercially? ?available,? ?classroom-based? ?economy? ?game? ?for? ?tablets? ?and Chromebooks? ?that? ?focuses? ?on? ?multi-digit? ?operations.? C?? S?? ?will?? ?encourage? ?conceptual understanding? ?and? ?build? ?math? ?self-efficacy? ?for? ?students? ?in? ?grades? ?K-5? ?within? ?the? ?context? ?of? ?a digital,? ?classroom-based? ?marketplace.? ?Within? ?the? ?game,? ?students? ?will? ?create? ?stores,? ?craft? ?objects to? ?sell,? ?engage? ?in? ?selling/purchasing? ?transactions,? ?and? ?work? ?together? ?to? ?increase? ?the? ?value? ?of? ?the economy.? ?In? ?addition,? ?the? ?game? ?will? ?utilize? ??artificial? ?intelligence? ?(AI)? ?to? ?detect? ?strategies? ?students use? ?and? ?help? ?teachers? ?facilitate? ?rich? ?mathematical? ?discussions? ?thereby? ?enhancing? ?students? reasoning? ?skills. Outcomes.? ??The? ?proposal? ?will? ?encourage? ?three? ?main? ?outcomes,? ?namely:? ?1)? ?algorithms? ?for detecting? ?math? ?strategies? ?students? ?use,? ?2)? ?a? ?discussion? ?support? ?dashboard,? ?and? ?3)? ?algorithms for? ?predicting? ?at-risk? ?status.? ?A? ?key? ?research? ?aim? ?is? ?to? ?determine? ?whether? ?the? ?software? ?can? ?predict math? ?strategies? ?students? ?use? ?and? ?detect? ?which? ?students? ?are? ?at-risk? ?academically? ?as? ?compared to? ?standardized? ?assessment? ?data,? ?which? ?will? ?help? ?teachers? ?intervene? ?appropriately.? ?The discussion? ?support? ?dashboard? ?will? ?help? ?to? ?promote? ?rich? ?mathematical? ?discussion,? ?thereby improving? ?students?? ?mathematical? ?justification? ?and? ?conceptual? ?understanding.? ?The? ?engaging game? ?will? ?bolster? ?students?? ?motivation? ?and? ?self-efficacy? ?in? ?mathematics. Improving? ?students?? ?academic? ?outcomes? ?and? ?self-efficacy? ?in? ?base? ?ten? ?during? ?elementary school? ?will? ?promote? ?later? ?success? ?in? ?high? ?school? ?mathematics.? ?Since? ?the? ?number? ?of? ?advanced math? ?classes? ?students? ?take? ?is? ?correlated? ?with? ?likelihood? ?to? ?complete? ?a? ?STEM? ?degree,? ?(Chen, 2013)? ?a? ?distal? ?outcome? ?of? ?this? ?proposal? ?is? ?increasing? ?students? ?pursuing? ?careers? ?in? ?STEM.

Public health relevance
Project Narrative There is an enormous need for students majoring in the fields of Science, Technology, Engineering and Mathematics (STEM), yet lacking a strong foundation in mathematics makes students, especially women, minorities and those from low-income backgrounds, less likely to pursue careers in STEM. Class Store will bolster students’ mathematics abilities, including mathematical reasoning and self-efficacy, in the foundational area of N umber and Operations in Base 10 in the short and long term. This will, in turn, lead to several positive distal outcomes, such as increased STEM majors and careers.